Chemical Probe Development for Epigenetic Complexes Enabled by Protein-Observed 19F NMR

PROJECT SUMMARY
Our long-term goal is to develop new chemical probes to dissect the molecular mechanisms associated with
epigenetic-complexes and transcriptional regulation. Establishing detailed mechanisms for the dynamic
regulation of gene expression remains a significant challenge for the field of epigenetics. Our research
program is addressing these challenges by developing selective chemical probes, discovery of new protein-
protein interactions, and improving structural biology and biophysical approaches to quantify these dynamic
multivalent interactions. These approaches are helping to create a detailed picture of diverse molecular
assemblies of epigenetic complexes and facilitating development of new epigenetic therapies.
Bromodomain-containing proteins are a subset of epigenetic reader protein, and are an emerging protein-
drug class for epigenome therapy. My research program is developing chemical biology approaches to study
two specific bromodomain-containing proteins, BPTF and BRD4. One innovation behind our approach uses a
19F NMR protein-based methodology for the discovery of isoform selective bromodomain inhibitors. Due to the
hyper-responsive nature of fluorine to ligand binding and simplified spectra, this structural biology tool is ideally
suited to rapidly screen small molecules, characterize the transient interactions associated with native
transcription factor-protein interactions, and to quantify the dynamics of the interactions from micro to
millisecond timescales. Over the next five years, we will further develop this approach for enabling small
molecule discovery, characterizing large (> 50 kDa) proteins, and quantifying the affinity and dynamics of
multidomain proteins associated with synthetic nucleosomes. With their discovery enabled by 19F NMR, our
new chemical probes for BPTF reader domains have potential for high impact as chemical tools for inhibiting
cancer progression and regulating autophagy, while more specific BRD4 chemical probes will help uncover
new biology in cancer and inflammation obscured by less specific tool compounds. We will use these tools to
dissect the functional roles of these bromodomains on transcription, including gene regulation, chromatin
engagement, and novel-protein-protein interactions. Next generation chemical probes will be further
developed including bifunctional molecules as inhibitors of multi-domain proteins, PROTACs with improved
selectivity profiles, and synthetic transcription factors through conjugation to DNA-targeting polyamides.
This proposal has broad biomedical significance for early lead discovery and studies of epigenetic reader
domains important in human health and disease. Given that epigenetic proteins represent a major class of
potential drug targets, our new 19F NMR small molecule discovery method and cell-based approaches for
epigenetic reader domains described here could significantly increase the repertoire of targets and thereby
open up new avenues for drug discovery.

Public health relevance
Project Narrative: Public Health Relevance Section A combined chemical and genetics-based approach is being developed for the discovery of highly domain selective bromodomain inhibitor molecules for the epigenetic proteins BRD4 and BPTF. Inhibiting transcription factor function mediated by epigenetic proteins is a powerful but challenging approach for controlling disease. Our newly developed chemical probes and structural biology approaches described here will help establish distinct molecular mechanisms used by bromodomain-containing proteins for transcriptional regulation and for ultimately treating disease.